Site-specific DNA recombinase and A/E pathogen virulence

Project Summary Foodborne disease is an important health threat and an immense economic burden worldwide. One important category of causative agents of foodborne diseases is attaching and effacing (A/E) pathogens, which include human pathogens enteropathogenic Escherichia coli (EPEC), enterohemorrhagic E. coli (EHEC) and their murine equivalent Citrobacter rodentium (CR). A/E pathogens share most of their genes and pathogenic mechanisms to subvert host signaling pathways and immune responses. Particularly, increasing number of studies demonstrate that A/E pathogen infections cause more severe morbidity and mortality in immunocompromised hosts. However, the critical host-pathogen interactions in the gut and the mechanism(s) through which A/E pathogens suppress host immune responses have not been fully understood, especially under immunocompromised condition. Our recent studies demonstrate that a novel site-specific DNA recombinase (Ssr) plays a crucial role in CR infection-caused severe morbidity and mortality in immunocompromised animals. This project aims to elucidate the pathogenic role of Ssr in CR infection- induced pathogenesis in immunocompromised hosts and the relevance of Ssr in human A/E pathogens. Thus, we will assess the impact of Ssr on colonic inflammatory response and epithelial integrity during A/E pathogen infections in Aim 1 and elucidate the molecular mechanism(s) through which Ssr affects virulence gene expression during A/E pathogen infections in Aim 2. At the conclusion of these studies, we will provide novel insights into the complex foodborne pathogenesis whereby A/E pathogen virulence is elegantly regulated during infections. It will also advance our understanding of the sophisticated pathogen-host interactions that may lead to novel strategies for prevention and treatment of A/E pathogen infections and foodborne diseases, especially under immunocompromised conditions.

Public health relevance
Public Health Relevance This project aims to assess the significance of a novel DNA recombinase in attaching/effacing (A/E) pathogens in bacterial infection-caused pathogenesis in the colon and to elucidate the mechanism(s) through which the DNA recombinase regulates virulence gene expression in A/E pathogens. Hence, this study will substantially increase our understanding of the sophisticated mechanisms on the pathogenesis of foodborne diseases caused by A/E pathogens. Findings from our study may also lead to novel target(s) that may aid rational drug development for treating foodborne diseases.